HGRP logistical coordinating center

PROJECT SUMMARY (Project 3: HGRP logistical coordinating center)
The goal of the WashU-UCSC-EBI based Human Genome Reference Center (HGRC) is to maintain and update
the new human genome reference produced by the Human Genome Reference Program (HGRP) consortium
and to provide it to the scientific community. The goal of the HGRP Logistical Coordination Center (HGRP-LCC)
is to create an effective organizational unit and coordination structure for the consortium, to achieve highly
efficient operation of the HGRP. Towards this goal, we propose innovative and robust strategies that ensure the
synergistic interactions across the consortium. We will serve as the nucleus for facilitating all activities of the
HGRP consortium including organizing the annual meetings, engendering discussions across the network, and
holding regular coordination meetings and various conference calls. We will coordinate the repository and
clearing house for protocols, human studies information, data sharing and sample transfer agreements,
biomaterials, resources and reagents. We will develop a versatile internal HGRP web portal that will serve as a
virtual repository for all of the HRGP documentation and tools, and for keeping track of consortium activities
including publications. We will coordinate with the Outreach and Education unit to create a user-friendly
infrastructure for training, knowledge dissemination and data sharing, and more broadly aim to integrate HGRP
with knowledge and data resources from the larger global scientific community.